Impact of Emotions on Treatment Decisions About Low-Risk Thyroid Cancer

PROJECT SUMMARY
This K08 Career Development Award will address important gaps in the training of the applicant while
simultaneously generating new knowledge about the role of emotions in cancer-related treatment decisions, a
priority of the NCI. The incidence of thyroid cancer has increased at a rate faster than any other cancer, largely
due to increased diagnosis of small, low-risk cancers ≤ 2 cm with a 10-year mortality close to zero.
Overtreatment with total thyroidectomy occurs in the vast majority of these patients, resulting in significant
harms, excess morbidity, and costs to both patients and society without a clear benefit. Currently, a lack of
understanding about why patients prefer this extensive treatment limits our ability to reduce overtreatment of
low-risk disease. The proposed research seeks to address this gap by investigating the impact of emotions on
treatment decisions about small, low-risk thyroid cancer. The coordinated research and training proposal aims
to: 1) characterize the emotional and cognitive communication between patients and surgeons during
treatment decision making; 2) determine the relative value of treatment outcomes to patients undergoing total
thyroidectomy at the time of the decision compared to one year postoperatively; and 3) test the extent to which
increased emotionally supportive communication by surgeons is associated with decreased patient preference
for total thyroidectomy. The central hypothesis is that is that emotions, such as fear and anxiety, influence
patient-surgeon decision making about treatment for small, low-risk thyroid cancer leading to decisions that
over treat. Completion of these aims will facilitate mentored-training in decision science that is vital to Dr. Pitt's
career goals. The proposed training will fill key educational and experiential gaps in the psychology of decision
making and behavioral economics, which will be accompanied by methodologic training in qualitative research,
preference measurement, choice experimentation, and factorial design. The applicant will draw upon the
strengths of a diverse group of nationally and internationally recognized mentors with multidisciplinary
expertise in experimental psychology, surgical decision-making, behavioral economics, and thyroid cancer
treatment. This mentored training will support the applicant in becoming a successful surgeon-scientist with
unique research skills. The results of the proposed research will provide new understanding about the specific
role of emotions and emotionally supportive communication in treatment decisions in a low-risk cancer. At the
end of the proposed training period, Dr. Pitt will have the results and experience necessary to obtain R01
funding to adapt and test behavioral and educational interventions that incorporate emotional support, thus
reducing the harms and costs of overtreatment.

Public health relevance
PROJECT NARRATIVE Overtreatment is a significant public health problem that affects patients with low-risk thyroid and other cancers, resulting in unnecessary morbidity without improving length of life. This study will investigate the impact of emotions on treatment decisions in patients with small, low-risk thyroid cancer. By understanding the role of emotions in decision making for low-risk cancer, we will have the foundation needed to incorporate emotional support into interventions targeted at reducing the burden of overtreatment on patients and society.